Administrative Supplement for the NCI P30 CCSG to extend partnerships with comprehensive cancer control coalitions to study implementation of evidence-based cancer control interventions

SUMMARY/ABSTRACT The Fred Hutch/University of Washington Cancer Consortium (the Consortium) encompasses partners who work together to address the full spectrum of cancer research and programs in the Consortium's catchment area to reduce the burden of cancer among the populations we serve. The Northwest Portland Area Indian Health Board (NPAIHB) is a non-profit tribal advisory organization serving the 43 federally recognized tribes of Oregon, Washington (WA), and Idaho. The Consortium's Office of Community Outreach & Engagement (OCOE), in partnership with the NPAIHB, proposes a cancer control project entitled, “Indigenous Intergenerational Intervention to Address Cancer” in response to “Administrative Supplements for the NCI P30 Cancer Center Support Grants to extend partnerships with comprehensive cancer control coalitions to study implementation of evidence-based cancer control interventions.” Through a collaboration with NPAIHB's Northwest Tribal Comprehensive Cancer Program (NTCCP), the OCOE proposes to provide technical assistance to WA Tribes to implement evidence-based interventions that address breast cancer disparities as well as HPV vaccination rate disparities among Indigenous populations in the state through the following specific aims: 1. Empower participating Tribal communities to increase breast and colorectal cancer screening and HPV vaccination among Indigenous peoples in WA state by implementing a media campaign by and for Indigenous people. 2. Implement an intergenerational cancer control evidence-based intervention (EBI) to increase community access to breast cancer screening for Indigenous women and HPV vaccination for Indigenous youth by reducing structural barriers. 3. Evaluate the impact of this intergenerational cancer control intervention by examining: (1) the reach of the media campaign for breast and colorectal cancer screenings (views, shares, likes, comments) and (2) the numbers of resources and people who receive educational outreach and breast cancer screening or HPV vaccinations at the Indigenous intergenerational EBI events.

Public health relevance
PROJECT NARRATIVE The Fred Hutch/University of Washington Cancer Consortium's Office of Community Outreach & Engagement, in partnership with the Northwest Portland Area Indian Health Board's Northwest Tribal Comprehensive Cancer Program, proposes a cancer control project entitled, “Indigenous Intergenerational Intervention to Address Cancer” to extend their partnership to disseminate and implement evidence-based cancer control interventions (EBIs). The proposed work will catalyze activities of special relevance to Tribes in Washington and will rely on extending partnerships with two tribal comprehensive cancer control coalitions, which have long experience in working to advance cancer prevention and control goals in Tribal communities.